BINDING OF SPIN LABELED NUCLEOTIDES TO PHOSPHORIBULOKINASE

The activated spin label 3-(2-bromoacetamido)proxyl modifies the sulfur atom of phosphorothioate-containing AMP, ADP, and ATP analogs in facile reaction that produces a new class of spin-labeled nucleotides. One of these products, adenosine 5 -O-(S-acetamidoproxyl 3-thiotriphosphate) (ATP SAP), has been evaluated as a structural probe for Rhodobacter sphaeroides phosphoribulokinase (PRK). When incubated with affinity-purified enzyme that contains tightly-bound substrate, ATP, ATP SAP binds non-cooperatively to the allosteric site (n = 1; KD = 8 fM). Probe bound in this site is displaced (K1/2 = 100 fM) by the allosteric effector, NADH, at concentrations comparable to those required for enzyme activation (Ka = 133 fM). In the presence of NADH, when the substrate site of PRK is vacant, ATP SAP binds in a cooperative mode (Hill coefficient w3; KD = 20 fM). In the absence of NADH, ATP SAP mimics ATP by exhibiting nonequilibrium binding to PRK. The observations with phosphoribulokinase, together with the straightforward nature of the methodology documented for synthesis and isolation of this class of spin-labeled nucleotides, suggest that these analogs have potentially wide application as structural probes.